VEGF Gene Delivery In The Primate To Prevent Defective Spiral Artery Remodeling And Maternal Vascular Dysfunction

PROJECT SUMMARY/ABSTRACT
During early human pregnancy, placental extravillous trophoblasts invade and remodel the uterine spiral
arteries into distensible low-resistance vessels to promote placental perfusion and thus fetal development. A
defect in uterine spiral artery remodeling (SAR) is the primum movens step that underpins adverse human
pregnancy, particularly preeclampsia, which leads to systemic vascular dysfunction in and increased morbidity
and mortality of the mother and offspring. However, there are no experimental primate models of defective
SAR, noninvasive methods to detect the defect in SAR in early pregnancy or therapeutic modalities to prevent
the maternal and offspring vascular dysfunction. We established a model of impaired SAR by slightly elevating
estradiol in the first trimester of baboon pregnancy. This model is characterized by a decrease in extravillous
trophoblast vascular endothelial growth factor (VEGF) expression, increase in placental expression and
maternal serum levels of the soluble fms-like tyrosine kinase-1 receptor (sFlt-1) that suppresses VEGF
bioavailability, maternal (published) and offspring (preliminary) vascular dysfunction, reduced fetal growth and
increased incidence of perinatal demise. We also employed B- flow/spatio-temporal image correlation (STIC)
M-mode ultrasonography to detect SAR impairment in early pregnancy. Importantly, ultrasound-
mediated/microbubble-facilitated gene delivery (UMGD) of VEGF to the placental basal plate of estradiol-
treated baboons early in pregnancy abolished the defect in SAR. However, it has not been established
whether reversing the defect in SAR by UMGD of VEGF will prevent maternal and offspring vascular
dysfunction. The foundation built upon this primate model during the recent R01 HD 93070 project period,
provides a highly unique opportunity to test the novel hypothesis that VEGF gene delivery to restore SAR will
prevent vascular dysfunction in the mother, fetus and offspring. Baboons will be untreated, treated with
estradiol to suppress SAR or treated with estradiol and UMGD of VEGF to reverse SAR impairment. Normal
and defective SAR will be determined by B-flow/STIC M-mode ultrasonography in the first trimester. Vascular
function will be quantified in the mothers and fetuses at midgestation and near term and the offspring at 0.5,
1 and 4 years after birth. Systemic microvessel endothelial function will be ascertained by quantifying
microvessel endothelial cell-specific nitric oxide synthase (eNOS) and VEGF mRNAs by RT-PCR and protein
levels by proximity ligation assay and capillary density by image analysis. Microvessel endothelial function will
be assessed in mothers and offspring by brachial artery flow-mediated dilation and microvessel flow by
contrast-enhanced ultrasonography (CEU) before and after hyperemia induced shear-stress and
acetylcholine with/without L-name administration. This study will be highly significant in establishing a
therapeutic modality to prevent the maternal and infant vascular dysfunction that is caused by improper SAR.

Public health relevance
NARRATIVE This study will be highly significant in establishing a therapeutic modality to prevent the maternal and infant vascular dysfunction that is caused by improper SAR early in pregnancy. Non-invasive UMGD delivery of VEGF selectively to the maternal aspect of the placenta represents an innovative approach to reverse the decline in SAR and link it to vascular function in the mother and offspring. Reversing the defect in SAR by VEGF gene delivery will be foundational in developing a similar therapeutic modality to prevent the devastating complications of vascular dysfunction in the human mother and newborn elicited by impaired SAR.